Cancer Center Administration

Cancer Center Administration: Admin Core
Project Summary
The Purdue University Center for Cancer Research (PCCR) was established as a National Cancer Institute
basic science cancer center in 1978. As an NCI basic science cancer center, the PCCR's mission focuses on
basic discovery - discovery through Foundational Disciplines that the PCCR fosters for innovative cancer
solutions. The PCCR has embraced key opportunities for enhancing the impact of its administrative unit and has
laid a new foundation for improving the elements that facilitate cancer research at Purdue University. During the
last project period, administration milestones attained include: (1) facilitating and coordinating the planning and
establishment of a new strategic plan; (2) implementing new information technologies for improved data
management; and (3) successfully managing the core functions of the Cancer Center Support Grant. In order to
meet and exceed the growing needs of the PCCR membership, the PCCR Administrative Core has the following
specific aims: (1) execute administrative operations that include providing oversight and management of shared
resources, managing the membership processes, coordinating the processes and monitoring for pilot projects,
managing PCCR-controlled spaces, arranging and documenting Center meetings, monitoring Center finances,
and overseeing activities relevant to the CCSG grant application process; and (2) enhance informatics for more
informed decision making by the Research Program leaders and Senior Leadership.